Integrated Care Plans and Health Care Quality, Outcomes, and Equity for Medicare-Medicaid Dual Eligible Beneficiaries with Multimorbidity, Frailty, or Dementia

PROJECT SUMMARY / ABSTRACT
Integrating coverage for dually eligible Medicare-Medicaid beneficiaries (‘duals’), a population with complex
medical and social needs, is a national priority. There is substantial concern that duals in non-integrated
Medicare Advantage (MA) plans or Traditional Medicare receive ineffective, inefficient, and potentially harmful
care due to unnecessary administrative burdens, lack of financial incentives for care coordination, and plans’
perverse incentives to shift costs across bifurcated insurance programs. To address this concern, policymakers
have sought to expand integrated care plans (ICPs)—managed care plans that coordinate care and manage
both Medicare and Medicaid services for duals. However, only ~1 in 10 duals is currently enrolled in an ICP.
Furthermore, in recent years, a major threat to integration has emerged in the form of non-integrated Dual-
Eligible Special Needs Plans (D-SNP) “look-alike” plans. These “look-alike” plans primarily serve duals, but
unlike ICPs, they are not subject to federal and state requirements to provide coordinated Medicaid services. In
2023, the Centers for Medicare and Medicaid Services (CMS) instituted a new “80% rule” in which it stopped
renewing contracts with any conventional, non-integrated MA plan where 80% or more of enrollees are duals.
However, it remains unclear whether this policy will curb the growth of look-alike plans, catalyze enrollment in
ICPs (especially among high-risk duals with dementia, mental illness, frailty, and from minoritized groups, who
may disproportionately benefit from integrated coverage), or lead to meaningful improvements in quality,
equity, and outcomes. Therefore, in Aim 1, we will evaluate the impact of the CMS 80% rule on enrollment
changes of duals from look-alike plans into ICPs, and we will identify patient-, market-, and community-level
factors associated with ICP enrollment. In Aim 2, we will determine the impact of the CMS 80% rule as a
natural experiment—using a control group of plans slightly below the 80% threshold—to examine its effects on
potentially avoidable or low-value care among duals previously enrolled in look-alike plans, and between duals
who transition to ICPs vs. non-ICPs. Aim 3 will determine the impact of the 80% rule on changes in quality and
clinical outcomes among duals from look-alike plans, and among those who transitioned into ICPs vs. non-
ICPs. Across all aims, we will assess the impact of the 80% rule on a subset of high-risk duals who experience
worse quality of care at baseline and have high levels of potentially avoidable and low value health care use,
including duals with dementia, frailty, serious mental illness, complex multimorbidity, and among historically
marginalized Black and Latino people. This study will provide critical insight into the effectiveness of the CMS
policy to expand integrated care among duals, using the termination of plans above the 80% threshold as a
natural experiment. It will also inform ongoing policy efforts—including consideration of revised federal
regulation of look-alike plans—to ensure better care integration, quality, and equity of care for duals.

Public health relevance
PROJECT NARRATIVE A major threat to national efforts to better integrate health care for dual eligible Medicare-Medicaid beneficiaries (‘duals’), a population with complex medical and social needs, has emerged in the form of non- integrated Medicare Advantage (MA) Dual-Eligible Special Needs Plans (D-SNP) “look alike” plans, which circumvent all state and federal regulations to coordinate health care for duals. Using a quasi-experimental study design and national Medicare-Medicaid administrative data, this study will evaluate the impact of a 2023 federal regulation—the “80% rule"—that eliminates “look-alike” plans on: 1) enrollment changes into integrated care plans (ICPs, which have the potential to improve quality, efficiency and outcomes for duals) and the key factors associated with ICP enrollment, 2) potentially avoidable or low-value health care use, and 3) quality of care and clinical outcomes among duals overall (plus a subset of high-risk duals with dementia, mental illness, frailty, multimorbidity, and from minoritized groups), and among duals who transitioned into ICPs vs. non-ICPs. Findings from this study will guide policymakers’ efforts to improve integrated care for duals—including consideration of further regulation to eliminate the full threat of look-alike plans—to better meet the needs of some of our country’s most medically complex and socially vulnerable people.